Factors Associated With Response To Drugs and Treatment

Drug abusers vary widely in their acute and chronic responses to drugs and in their response to drug abuse treatment. A better understanding of the factors associated with individual differences in response should result in the development of more effective and efficient treatment. This project assesses biological and psychosocial characteristics of drug abusers and correlates them with abusers' response to their abused drug, their biomedical consequences from drug use (such as HIV infection), or to the abusers' treatment outcome. One component is evaluating the psychological, physiological, and neuropharmacological manifestations and time course of cocaine withdrawal, with the goal of identifying predictors of relapse to cocaine use. This study, in collaboration with the Department of Radiology, Johns Hopkins University, uses positron emission tomography (PET) scanning with 11C-carfentanil (a synthetic, potent mu-opiate receptor agonist) to evaluate the effect of chronic cocaine abuse on mu-opiate receptor function in the brain. Results indicate that chronic heavy cocaine users have increased mu-opiate receptor binding in some brain regions (compared to non-drug using healthy controls), which correlates with their self-reported cocaine craving. The increased binding persists over 90 days of cocaine abstinence, while psychological (e.g., cocaine craving, mood) and physiological parameters (sleep, heart rate) normalize over 7-10 days. The more receptor binding normalized over the 90 days, the longer until subjects relapsed to cocaine use after discharge from the research ward. Furthermore, in subjects receiving a cocaine challenge during PET scanning, the acute change in binding caused by cocaine correlated significantly with the subjective effects produced by the cocaine challenge. These findings suggest an important role for the brain mu-opiate system in cocaine addiction, with interesting treatment implications. The current phase of this study evaluates additional neurophysiological measures such as electroencephalogram (EEG) and cerebral blood flow by transcranial Doppler (in collaboration with Molecular Neuropsychiatry Section). Preliminary findings suggest that IV cocaine use produces acute but very transient increases in middle cerebral artery blood flow. A second component assesses psychiatric and medical co-morbidity (including HIV infection), personality traits, mood, neuropsychological function, and sociodemographic characteristics in drug abusers using structured and semi-structured diagnostic interviews and computer-administered psychological tests. Preliminary findings suggest that age and lifetime psychiatric comorbidity have little influence on drug abuse treatment outcome, while gender does. For example, lifetime (and current) pathological gambling had no influence on treatment outcome. A third component evaluates the subclinical effects of acute and chronic cocaine use on cardiovascular function, using 24-hour ambulatory monitoring, high-resolution EKG, echocardiography, and analysis of heart rate variability. Preliminary findings suggest that heavy cocaine users may have subtle changes in autonomic regulation of heart rate in response to posture changes, but no significant changes in circadian variation of heart rate and blood pressure. A fourth component is evaluating individual differences in activity of the main cocaine-metabolizing enzyme in humans, butyrylcholinesterase, and of various neurotransmitter-associated genotypes (in collaboration with the Molecular Neurobiology Branch) as factors influencing the acute response to cocaine.